Daily Self-Weighing for Obesity Management in Primary Care

PROJECT SUMMARY/ABSTRACT
Most adults with obesity continue to gain weight. While primary care clinical guidelines recommend provision
of, or referral to, intensive weight management treatment for patients with obesity, there are significant barriers
to delivery. Even if offered, many patients do not have the time or resources to participate. Given this, along
with the challenges of losing weight and keeping it off, a harm reduction framework focused on disrupting
continued age-related weight gain among primary care patients with obesity may be a strategy to mitigate
obesity's adverse health effects. Self-regulation theory suggests that daily self-weighing (DSW; i.e., instruction
to weigh daily and monitor weight) offers a simple way to promote weight management among patients with
obesity. We, and others, have shown that DSW associates with better weight management and may be ideal
for primary care because of its low-burden and consistency with clinical guidelines recommending self-
monitoring of health parameters such as blood pressure and glucose. However, DSW's effect when
implemented in primary care among adults with obesity is unknown. Therefore, we propose conducting SWOP
(Daily Self-Weighing for Obesity Management in Primary Care), a 24-month randomized controlled trial
(RCT) in 400 adults with obesity (i.e., body mass index [BMI]: kg/m2 ≥30) receiving primary care through a
clinical network affiliated with the University of Alabama at Birmingham (UAB). Enrolled participants will receive
weight management educational materials and then randomized to DSW or standard care (SC). DSW will
involve provision of a web-enabled digital scale with graphical weight feedback, while SC will involve routine
care. We will test the causal effect of assignment to DSW on weight (primary outcome) and self-initiated
adoption of weight management practices (secondary outcomes) over 24 months (Aim 1). We will also test the
causal effect of DSW adherence on weight and weight control practices (Aim 2). Finally, we will evaluate the
cost effectiveness of DSW compared to SC (Aim 3). Results will allow us to estimate whether DSW mitigates
continued age-related weight gain among adults with obesity. If so, DSW could have substantial public health
and economic effects by offering a weight management strategy that is feasible to implement in primary care.

Public health relevance
RELEVANCE Many adults with obesity continue to gain weight even though they do not want to. This project will test the effects of a primary care intervention in which people with obesity receive an electronic scale and recommendations to weigh themselves daily. This will help us understand whether daily self-weighing might be a way to prevent continued weight gain.